In vivo imaging platform for DM1 drug discovery

PROJECT ABSTRACT/SUMMARY
Myotonic dystrophy type 1 (DM1) is a multisystemic disorder caused by CUG repeat expansion
in the 3’ UTR of the DMPK gene. DM1 patients can have between 50 to 5,000 CUG repeats,
leading to DMPK mRNA aggregation within the nucleus. These ribonuclear clusters, termed foci,
sequester several splicing factors, such as muscleblind-like (MBNL) proteins, and transcription
factors, leading to dysregulation of splicing, miRNA and circRNA formation, and mRNA location
and stability. DM1 is the most common adult form of muscular dystrophy and affects 1 in 8,000
people worldwide. There is currently no cure for DM1 and treatment consists of symptom
management. Recent advances in RNA-focused drug library design and screening tools now
allow better, more biologically relevant hit screening that overcome traditional protein-based drug
discovery approaches. However, appropriate animal models for efficient preclinical testing of
RNA-focused drug candidates remained lacking. Pharmacokinetic and target engagement
studies for every new drug candidate still rely on biochemical measurements in harvested tissues,
which is expensive, time consuming, and requires large numbers of animal sacrifice. There is
currently no in vivo model capable of monitoring toxic foci and MBNL sequestration, the trigger of
DM1 disease phenotype, in real time high-throughput format, and in a non-invasive manner to
limit the number of animals needed. The goal of this SBIR Phase I project to develop an in vivo
reporter platform that allows more efficient evaluation of triaged drugs and lead compounds for
target engagement and other PK metrics. We will use our proprietary fluorogenic RNA aptamer
technology to develop in vivo reporters that can detect drug-induced changes in toxic foci
formation and CUG-MBNL interaction. In Phase, I we will demonstrate the feasibility of the in vivo
reporter system in DM1 model cell lines and animal model and in Phase II, we will generate
transgenic reporter animals, perform preclinical testing with collaborator lead compounds, and
expand the platform capability toward other microsatellite diseases.

Public health relevance
PROJECT NARRATIVE 1 in 8000 people will develop myotonic dystrophy type 1 (DM1), a multisystemic disorder characterized by myotonia, muscle wasting, cataracts, cognitive defects, and cardiac conduction issues. DM1 is a RNA gain-of-function disorder characterized by trinucleotide tract expansion in the nucleus that leads to downstream effects. We propose to develop an in vivo DM1 reporter system that enables non-invasive and efficient preclinical evaluations of drug candidates in animal models.